Mechanism of the Membrane-Associated Accessory Protein (MAAP) in rAAV Production

PROJECT SUMMARY
Recombinant adeno-associated virus (rAAV) vectors have emerged as one of the preferred gene delivery
agents for clinical gene therapy. To date, two rAAV-based drugs, Luxturna and Zolgensma, have been
approved by the US FDA, and over 230 clinical trials of human gene therapy using rAAV vectors have been
carried out or are ongoing, and some have yielded positive outcomes. However, various barriers still remain
that need to be resolved for rAAV to be used as a vector in human applications, including lack of a simplified
high yield vector production system. Recently, a novel AAV nonstructural protein, membrane-associated
accessory protein (MAAP), was discovered during a comprehensive AAV capsid fitness study. MAAP is
translated from a non-canonical start codon from the AAV capsid protein gene-encoding region, and has been
predicted to be in the genera of the Dependoparvovirus A&B of the Parvoviridae family, which share a high
similarity in amino acid sequence. MAAP is associated with the cell surface membrane through a predicted α-
helix transmembrane domain at the C-terminus. However, it is also localized to the nuclear membrane and is
expressed in both the nucleus and the cytoplasm. Infection of a MAAP knockout AAV showed that the capsid
is restricted in the nucleus. Knockout of MAAP in rAAV production has shown MAAP is a key viral factor that
mediates cellular egress of rAAV vectors through vesicle secretion pathways. As MAAP does not interact with
the AAV capsid, how MAAP mediates transportation of AAV virions from the nucleus to cytoplasm and out of
the cell surface membrane is unknown. rAAV vectors purified from the culture medium is a simplified vector-
manufacturing method, avoiding the more complex and time-consuming process of the treatment of the cell
lysates. And, rAAV vectors purified from extracellular vesicle (EV) as enveloped EV-rAAV possess certain
advantages in gene delivery. Therefore, an efficient means to extracellularly secret rAAV in the culture medium
will help establish a simplified high yield vector production system and improve EV-rAAV production. Our
overall hypothesis is that MAAP facilitates AAV nuclear export, cytoplasmic trafficking, and cell surface
membrane exit, which are all important for egress of both the wild-type AAV and rAAV. We will identify host
proteins that interact with MAAP, and will determine the route of the MAAP-mediated (both nuclear and
cellular) egress of AAV. Successful fulfillment of the proposed experiments will identify host proteins and
pathways that can be targeted to improve rAAV vector purification from cell culture medium. In addition, a full
understanding of the MAAP function in the AAV life cycle will provide deeper insight into our current knowledge
in parvovirology.

Public health relevance
PROJECT NARRATIVE Adeno-associated virus (AAV) expresses a novel membrane-associated accessory protein (MAAP), which has been implicated in facilitating extracellular secretion of recombinant AAV (rAAV) during vector production in HEK293 cells. The proposed study will identify the function of MAAP in AAV nuclear export and cellular egress, which will help simplify rAAV vector production using only cell medium.